Interstitial Chemophototherapy with Light-Activated Nanoparticulate Doxorubicin

Summary
Our goal is to commercialize interstitial chemo-phototherapy (I-CPT) as a new therapeutic option for locally
advanced liver cancers. Doxorubicin (Dox) can be actively loaded into long circulating, serum-stable, porphyrin-
phospholipid (PoP) liposomes and be released with 665-nm laser light (PhotoDox). This approach leads to vastly
enhanced drug accumulation in irradiated tissues, resulting in ultrapotent tumor ablation. In the phase I STTR,
we employed this dosimetry-treatment planning platform to guide light administration of I-CPT with PhotoDox.
We demonstrated that this treatment planning with light dosimetry is effective in ablating large orthotopic
hepatocellular carcinoma tumors in rats. In this phase II STTR application we propose to further advance I-CPT
with PhotoDox towards an IND for enabling future clinical studies. To that end we propose to complete the
following aims: Aim 1: Optimizing I-CPT with PhotoDox for a durable complete response of large spontaneous
hepatocellular carcinoma in a woodchuck model. The woodchuck model is the largest experimental animal model
with spontaneous locally advanced hepatocellular carcinoma (HCC) in the context of chronic viral hepatitis and
liver cancer, as seen in people with hepatitis B. In pilot studies, we have safely dosed PhotoDox to woodchucks,
confirmed the characteristic long-circulating nature of PhotoDox and applied the FEM based treatment planning
and dosimetry to safely treat HCC (~50 cm3) with I-CPT in woodchucks. We will address the key question: What
are the optimal light settings for I-CPT with PhotoDox in the treatment of large HCC? Aim 2: Generate IND-
enabling data on the toxicity of I-CPT with PhotoDox. POP BIO has previously generated non-GLP toxicity data
of PhotoDox in rats including cursory establishment of the maximum tolerated dose. Since then, POP BIO has
held a pre-IND meeting with the FDA, who confirmed the suitability of the 505(b)(2) route for components of
PhotoDox and provided guidance about the required toxicological studies required prior to first-in-human studies.
We will address the key question: What is the toxicity of PhotoDox under GLP studies? This translational Phase
II project will provide required data for an IND submission to the FDA by providing valuable relevant to
understanding I-CPT treatment in the context of human liver cancer patients. If successful, I-CPT with PhotoDox
stands to benefit the majority of new liver cancer patients, who have inoperable and problematic primary tumors.

Public health relevance
Narrative Patients with inoperable locally advanced hepatocellular carcinoma (HCC) have a 5-year survival rate of just 31%. The goal of this proposal is to advance a novel interstitial chemo-phototherapy (I-CPT) that combines PhotoDox, a light-activated liposomal formulation of doxorubicin, with MRI treatment planning developed by PI to provide a potent therapeutic option for locally advanced HCC. This will be accomplished by: optimizing I-CPT with PhotoDox for a durable complete response of large spontaneous hepatocellular carcinoma in a woodchuck model; and generating IND-enabling data on the toxicity of I-CPT with PhotoDox in two animal species (rat and dog).